Epigenomic markers of circulating cell-free DNA and treatment outcome in multiple myeloma

PROJECT SUMMARY
Multiple myeloma (MM) is a heterogeneous group of disorders with distinct bone marrow dependence, clinical
features, prognosis, and response to therapy. Despite the best available treatments, MM is generally incurable
and patients will eventually develop relapsed/refractory disease. Early relapse is associated with poor clinical
outcomes and overall survival. There are currently no effective markers that can predict which patients will
have early relapse. The long-term goal is to better understand the role of epigenetics in treatment outcomes of
MM and develop a non-invasive, clinically convenient approach for predicting relapse. The overall objective of
this application is to evaluate 5-hydroxymethylcytosines (5hmC) and 5-methylcytosines (5mC) in circulating
cell-free DNA (cfDNA) from MM patients as markers for predicting patients at high risk of early relapse at the
time of diagnosis. It is known that greater epigenetic heterogeneity is linked with poorer survival and relapse.
We propose that sensitive and robust cfDNA-based epigenetic markers may offer greater convenience and
minimal invasiveness for predicting early relapse in MM. In addition to 5mC, changes in 5hmC, an abundant
and stable modified cytosine with a distinct gene regulatory function from 5mC, have been implicated in cancer
development and pathobiology. However, due to technological constraints, previous studies of cancer
epigenetics have largely interpreted modified cytosines as 5mC only, and no study has evaluated the distinct
roles of 5hmC and 5mC in the therapeutic significance for MM. To fill the current research and technical gaps
and consider the high impact of developing a minimally invasive blood test for MM, we will utilize a highly
sensitive and robust technique developed by our team, the nano-Seal-Seq (a chemical labeling technique
integrated with the next-generation sequencing), to accurately determine 5hmC and 5mC profiles in cfDNA and
CD138+ myeloma “cancer” cells from bone marrow. The central hypothesis is that the 5hmC/5mC signatures
in cfDNA at diagnosis can distinguish MM patients by early relapse status. In Aim 1, we will profile 5hmC and
5mC in cfDNA from ~240 MM patients (relapse within 12 months [early relapse, n=120] vs. >12 months [late
relapse, n=120] of starting initial therapy) to develop an integrated predictive index for early relapse. We will
validate the 5hmC/5mC markers in two independent replication population of ~750 MM patients. In Aim 2, we
will profile 5hmC/5mC in 300 genomic DNA from CD138+ myeloma cells from patients with paired plasma
cfDNA to determine a bone marrow-based predictive index, of which the performance will be compared with
that of the cfDNA markers. In Aim 3, we will investigate change of 5hmC/5mC in serial cfDNA over time in 130
patients to characterize its therapeutic significance. The proposed research is highly significant, because it is
expected to vertically advance understanding of the biological basis for early relapsed MM and promote the
development of a new paradigm for epigenetic monitoring (and eventually, treatment) that has broad
translational importance in the personalized management of high-risk patients.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the identification of 5-hydroxymethylcytosine (5hmC) and 5-methylcytosine (5mC) modifications in circulating cell-free DNA (cfDNA) that may predict treatment failure (i.e., early relapse) at the time of diagnosis of multiple myeloma (MM), the 2nd most common hematologic malignancy and generally incurable, will provide the foundation for precision medicine. This contribution will be significant because patients at higher risk of early relapse could be treated with more aggressive strategies or with epigenetics-based neoadjuvant approaches. Thus, the proposed research is relevant to the part of NIH's mission that pertains to developing fundamental knowledge that will help reduce the mortality of multiple myeloma.